Nuclear envelope protein LEMD2 in heart

PROJECT SUMMARY
Mutations in genes encoding nuclear envelope (NE) components cause an array of diseases referred to as
nuclear envelopathies that often manifest as cardiomyopathies. The NE separates the nucleoplasm from
cytoplasm and is composed of outer and inner nuclear membranes. The nuclear lamina (NL) is an extensive
network of lamin polymers and associated proteins that are embedded in the inner nuclear membrane (INM).
Functionally, NL and INM proteins not only provide mechanical stability to the nucleus but also serve as the
anchoring point for chromatin at the nuclear periphery, playing a critical role in chromatin organization and
regulation of gene expression via interaction with and modulation of epigenetic machinery components. The
LAP2-Emerin-MAN1-domain (LEM-D) family of proteins play an important role in the association between the
NL and chromatin. LEMD2 (LEM domain-containing protein 2), is a transmembrane protein located in the INM,
involved in nuclear integrity and perinuclear tethering and transcriptional silencing of heterochromatin.
Recently, it has been reported that a single amino acid substitution of leucine 13 to arginine (L13R) in LEMD2
leads to autosomal recessive human cardiomyopathy. However, despite its clinical relevance, little is known as
to the specific role of LEMD2 in cardiomyocytes (CMs), and mechanisms by which the L13R mutation leads to
cardiomyopathy. To address this gap in knowledge, we have generated three mouse models: constitutive CM-
specific Lemd2 knockout (cKO), inducible CM-specific Lemd2 knockout (icKO), and LEMD2 L13R knock-in
mice. We will also utilize a human induced pluripotent stem cell (iPSC)-derived CM model of the LEMD2 L13R
mutation to address the impact of L13R mutation in LEMD2 on human CMs. Preliminary studies revealed that
loss of LEMD2 in embryonic or adult CMs is detrimental, and LEMD2 L13R mutation affects cardiac function in
a murine model, indicating that LEMD2 plays a critical role in maintaining normal CM structure and function in
developing and adult hearts. Thus, we hypothesize that LEMD2-mediated maintenance of NE integrity and/or
regulation of heterochromatin tethering and silencing is essential for CM structure and function, and LEMD2
L13R mutation impairs specific aspects of LEMD2 function leading to cardiomyopathy. Accordingly, Our
Specific Aims are: 1. To determine the role of LEMD2 in the developing and adult myocardium by analyzing
constitutive (cKO) and inducible (icKO) Lemd2 CM-specific knockout mice for heart morphogenesis, structure
and function, and the progression of cardiomyopathy; and 2. To elucidate molecular mechanisms underlying
cardiomyopathy consequent to the L13R mutation in LEMD2 by detailed analyses of LEMD2 L13R knock-in
mice and human induced pluripotent stem cell (iPSC)-derived LEMD2 L13R mutant CMs.

Public health relevance
PROJECT NARRATIVE While it is clear that LEMD2 L13R mutation results in cardiomyopathy, little is known as to the specific role of LEMD2 in cardiomyocytes and mechanisms by which LEMD2 L13R mutation leads to cardiomyopathy. Proposed studies are aimed at understanding the function of LEMD2 in the heart at the molecular, cellular, and physiological levels, and gaining insights into mechanisms by which LEMD2 mutation causes cardiomyopathy.